Administrative Core

PROJECT SUMMARY – Administrative Core (Core A)
The goals of the Administrative Core, located at the Northwestern University Feinberg School of Medicine, are
to provide coordination and integration of all Projects and Cores across Northwestern, National Jewish and
University of Calgary, as well as dissemination of resources, primary data, and scientific results with the other
Cooperative Centers on Human Immunology and to the public. The Administrative Core will accomplish these
objectives as outlined in four specific aims: 1) To support communication between Project Investigators, Core
Leaders, other Cooperative Centers on Human Immunology Sites, and NIAID Program Staff. In addition, Core
A will organize quarterly executive committee hybrid meetings, host an annual in-person scientific meeting of our
multidisciplinary investigators, and will host an annual external advisory board review. 2) To provide a structure
for the distribution of common resources, and regulatory and budgetary oversight for Project Investigators and
Core Leaders. 3) To disseminate the discoveries made by Neu-Lung Consortium Investigators through support
of publications and presentations, and to implement sharing of materials, protocols and raw data to other
institutions and investigators, including NIAID-directed public databases/repositories. 4) To foster an
environment of collaborative interdisciplinary research and mentoring of students, post-doctoral fellows, and
investigators. Core A will be led by Dr. Stephanie Eisenbarth, an accomplished immunologist with expertise in
both innate and adaptive immunity, and the inaugural director of the new Center for Human Immunobiology (CHI)
at Northwestern. Core A will be supported by the expertise of Dr. G. R. Scott Budinger, Chief of Pulmonary and
Critical Care Medicine at Northwestern and CHI advisory board member, and an institutionally supported CHI
Research Program Coordinator. The primary mission of the CHI is to foster collaboration and provide resources
for immunology-focused investigators at Northwestern. As part of that mission, monthly faculty working groups
have been formed to identify scientific synergy amongst CHI labs. This proposal is a result of the “Innate
Immunity in the Lung” working group, which brings together immunologists with expertise in neutrophil biology,
lung pathology, and immune disease modeling. Core A will continue to foster the interactions of this group by
hosting monthly hybrid meetings, an annual in-person scientific meeting and oversight of this U19 if awarded.
The CHI at Northwestern will provide important resources for this proposal if funded as the breadth of human
immunology grows on campus and new initiatives to support trainees focused on human immunology are
implemented.

Public health relevance
NARRATIVE A project narrative is not required for this component per instructions stated on the Funding Opportunity Announcement RFA-AI-22-069, “Project Narrative: Do not complete.”